The Differentiation and Function of heterogeneous populations of Allergen-specific Lung-resident Th2 CD4+ memory cells

Project Summary/Abstract
Asthma is an inflammatory disease of the airways characterized by acute, intermittent and recurrent episodes of
inflammation that can be induced by a specific allergen. CD4+ T cells contribute to this process by producing the
Type 2 cytokines IL-4, IL-5, and IL-13 and inducing B cell production of IgE in response to T cell receptor (TCR)
recognition of allergen peptides bound to MHCII molecules on host cells. In both murine models of disease and
asthmatic patients, quiescent allergen peptide:MHCII (pMHCII)-specific CD4+ memory T cells can persist in
lungs and lymphoid organs long after resolution of inflammation. Upon subsequent exposure to allergen, CD4+
memory T cells rapidly drive asthma-induced immunopathology making these cells attractive targets for allergen-
specific immune modulation. Little is known, however, about the function and maintenance of Th2 memory cells
that orchestrate the asthmatic response due to the challenge of tracking small populations of CD4+ T cells that
express allergen pMHCII: specific TCRs. To address this lack of knowledge, we produced an MHCII tetramer
containing a peptide from the Der p1 protein of the house dust mite (HDM), Dermatophagoides pteronyssinus,
the most common cause of atopic asthma. Using this tetramer and a novel magnetic bead-based cell enrichment
method of our design, we have found that IL-2 dependent, functionally heterogeneous populations of Th2 tissue
resident memory cells reside in the lung for long periods of time. The central hypothesis of this application is that
these distinct yet synergistic populations of Th2 “effector Trm” and B cell helping “Tfh Trm” contribute to asthma
pathogenesis in unique ways. The goals of this proposal are to identify the molecular and cellular mechanisms
that lead to Th2 Trm cell heterogeneity and determine how these cells persist in different regions of the lung.
This innovative approach could provide the means for targeting specific pathologic functions of memory Th2
cells by immunotherapy or eliminating them altogether.

Public health relevance
Project Narrative Asthma is an inflammatory disease of the airways that affects more than 300 million people worldwide and is increasing in incidence. This research will focus on understanding how allergen-specific CD4+ memory T cells that reside in the lung and orchestrate the response to the most common cause of allergic asthma, house dust mite, behave in response to subsequent allergen exposure. These studies will provide novel mechanisms to develop therapies that prevent and inhibit allergen-induced asthma.